The early and lasting mechanisms underlying predator odor stressor-induced adaptations to alcohol interoceptive sensitivity

PROJECT SUMMARY/ABSTRACT
Post-traumatic stress disorder (PTSD) can be precipitated by a traumatic stressor and is an enduring and
debilitating disorder for which only limited treatment options exist. Furthermore, PTSD increases an individual’s
likelihood to develop a co-morbid alcohol use disorder (AUD), demonstrating the importance of understanding
the brain mechanisms underlying the relationship between stress and alcohol sensitivity. Alcohol interoceptive
sensitivity refers to the subjective stimulus effects of alcohol on an organism. As such, interoceptive sensitivity
has the potential to inform alcohol intake (i.e., signal satiety or drive more drinking). However, due to clinical
limitations, little is known about brain mechanisms that underlie stressor-induced diminished sensitivity to
alcohol. Therefore, we propose to use a well-established predator odor exposure (2,5‐dihydro‐2,4,5‐
trimethylthiazoline (TMT)) stressor model in rats that has demonstrated lasting behavioral consequences
relevant to PTSD. Stress is associated with dysregulated cortical glutamate function. In agreement with the
clinical stress literature, I find altered expression of mGlu receptor gene expression in the rat cortex following
TMT exposure. Specifically, Grm3 (mGlu3) was downregulated in the prelimbic cortex (PrL) two days after
TMT exposure. Additionally, several NMDA receptor gene transcripts (GriN2A, GriN2B, GriN2C, GriN2D,
GriN3A, and GriN3B) were upregulated in the insular cortex (IC) 2 weeks after the TMT exposure. This is
important as NMDA receptors modulate expression of the interoceptive effects of alcohol, and my preliminary
data demonstrate diminished interoceptive sensitivity to alcohol in rats previously exposed to TMT at the same
time point (2 weeks after TMT). Because the IC is involved in alcohol interoceptive processing and is one of
the major outputs of the PrL, I hypothesize that plasticity induced by stress between PrL (mGlu3)IC circuitry
triggers the NMDA-related brain changes in the IC that may underlie the blunted sensitivity to the interoceptive
effects of alcohol. Aim 1 investigates the potential mechanisms that occur during the TMT stressor to promote
the changes to alcohol interoceptive sensitivity. Exp 1.1 uses an mGlu3 negative allosteric modulator (NAM) to
block mGlu3 receptor signaling in the PrL immediately prior to TMT exposure, and to determine if this
treatment prevents the attenuated sensitivity to alcohol 2 weeks later. Exp. 1.2 uses a chemogenetic approach
to silence glutamatergic projections from the PrL to the IC prior to TMT exposure, to assess if this treatment
will prevent the blunted alcohol interoceptive sensitivity. Aim 2 investigates whether the NMDA receptor
adaptations in the IC underlie the attenuated sensitivity to alcohol. Exp. 2.1 determines if TMT exposure
produces NMDA receptor adaptation in optically evoked EPSC’s from IC neurons receiving projections from
the PrL. Exp. 2.2 investigates the functional adaptations to IC NMDA receptors that underlie the attenuated
sensitivity to alcohol. Together, these experiments will elucidate the early and lasting brain mechanisms that
underlie stressor-induced adaptations to alcohol interoceptive sensitivity.

Public health relevance
PROJECT NARRATIVE Post-traumatic stress disorder (PTSD) confers a 3-times greater risk to develop a comorbid alcohol use disorder (AUD). However, very little is known about this relationship and only limited treatment options exist for both PTSD and AUD. Therefore, this project investigates the early and lasting mechanisms of a stress event that underlie lasting changes to alcohol sensitivity, which could advance the field’s understanding of the relationship between stress and alcohol sensitivity.